DNA Protein Cross-Links:Cellular Effects and Repair Mechanisms

Project Summary
DNA-protein cross-links (DPCs) are formed when proteins become covalently bound to DNA form
spontaneously as a result of normal cellular processes such as lipid peroxidation, histone demethylation, DNA
replication, transcription, and DNA repair. DPCs can be induced by exposure to anti-tumor drugs, transition
metals, UV light, and γ-radiation. DPCs interfere with many biological processes and are implicated in the
accelerated aging and increased cancer incidence observed in Ruijs-Aalfs syndrome patients. The goal of this
application is to map DPC lesions along the genome, investigate how human cells recognize and remove
these exceedingly bulky DPC lesions, and to identify the mechanisms by which they cause mutagenicity and
cell death. Our central hypothesis is that unrepaired DPCs compromise the efficiency and accuracy of DNA
replication and contribute to the toxicity and mutagenicity induced by the agents listed above. Our research
plan focuses on three aims. First, will use next generation sequencing in combination with affinity pull down
and protein precipitation to identify specific genomic regions susceptible to spontaneous and xenobiotic-
induced DPC formation in human cells. Second, we will elucidate the role of proteolytic processing in DPC
repair. Affinity capture, unbiased searches, and candidate gene-based approaches twill be used to identify
proteins required for proteolytic processing and repair of DPCs, determine how cells convert DPCs to smaller
peptide lesions (DpCs), and identity critical DNA repair proteins required for DPC removal from the genome.
Third, we will investigate the effects of DPCs and DpCs on DNA replication. Our in vitro studies using DNA Pol
η showed that efficiency and fidelity of translesion synthesis past peptide DpCs is strongly dependent on DNA
sequence context. We will examine the effects of sequence context on bypass efficiency and mutagenicity in
human cells. The structural basis for the context effects on the efficiency and fidelity of bypass will be studied
by molecular modeling and NMR studies. We will use a newly developed assay that employs pigyBac
transposition of DpC or DPC containing DNA to examine the effects these lesions have on chromosome
replication. These studies will for the first time examine the biological outcomes of structurally defined
chromosomal DPCs in human cells.

Public health relevance
Project Narrative Exposure to a wide variety of agents including occupational and environmental pollutants, anticancer drugs, and chemical species produced naturally as a result of cellular metabolism can cause proteins to become covalently attached to DNA. Failure to repair these DNA-protein cross-links can result in adverse outcomes, including cell death, oncogenesis, and other age-related pathologies. The goals of this project are to understand how DNA protein crosslinks are recognized and repaired, as well as to understand mechanisms of damage tolerance.